Characterizing Respiratory Syncytial Virus Burden and Prevention in the United States

Respiratory syncytial virus (RSV) is the most common viral cause of lower respiratory tract infection (LRTI) in infants globally, but also leads to severe outcomes among non-infant, high-risk adult populations. Mathematical models have been used to characterize RSV burden, but estimating the impact of interventions is often limited to a single target population (e.g., pediatric, maternal, or the elderly). Until recently, the only option for prevention of RSV was the monoclonal antibody, palivizumab, but there is now a substantial active pipeline of vaccine candidates and monoclonal antibodies targeting multiple risk groups, both licensed and in development. Due to the high morbidity and mortality from RSV, it is critical to assess population-level effectiveness of new interventions prior to introduction so that resources can be prioritized on interventions and delivery schedules that have the highest impact. In this research project, I will characterize RSV burden and prevention strategies in multiple risk groups in the United States. I propose to develop an agent-based modeling framework that enables timely incorporation of the most current understanding of RSV infection and calibration to epidemiologic data accounting for seasonality, social contact rates, immunity from prior infection, and maternal antibody transfer. This work will establish a detailed understanding of RSV risk and RSV natural history and produce updated estimates of RSV burden and cost-effectiveness of RSV prevention in the United States as new interventions are introduced and require assessment. This work will also demonstrate the value of both agent-based dynamic modeling and individual-level risk factors in characterizing and addressing optimal strategies for RSV prevention. I will first calibrate and apply the modeling framework to estimate health outcomes, including novel outcomes such as long-term sequelae and out-of-hospital mortality, in the United States, and subsequently extend the modeling framework to incorporate cost data and estimate the cost-effectiveness of RSV prevention in the United States. The analytic approach of agent-based, transmission dynamic modeling will provide flexibility in addressing prevention among different target populations with a combination of intervention strategies, incorporating the latest results of clinical trials. The overall goal of this work is to improve population health through characterizing RSV burden and potential prevention strategies. Through this award, I will learn crucial skills for taking the next step in my career as an independent researcher dedicated to improving vaccine access and delivery.

Public health relevance
The findings of this study will identify RSV prevention strategies that are both effective and cost-effective, and underscore areas where further data collection and research are needed. Through assessment of high-value interventions, this work will inform prioritization of RSV prevention efforts in the United States, in terms of both population health and economic impact. 1. Falsey AR, Hennessey PA, Formica MA, Cox C, Walsh EE. Respiratory syncytial virus infection in elderly and high-risk adults. N Engl J Med 2005; 352(17): 1749-59. 2. Glezen WP, Greenberg SB, Atmar RL, Piedra PA, Couch RB. Impact of respiratory virus infections on persons with chronic underlying conditions. Jama 2000; 283(4): 499-505. 3. Glezen WP, Taber LH, Frank AL, Kasel JA. Risk of primary infection and reinfection with respiratory syncytial virus. Am J Dis Child 1986; 140(6): 543-6. 4. Hall CB, Weinberg GA, Iwane MK, et al. The burden of respiratory syncytial virus infection in young children. N Engl J Med 2009; 360(6): 588-98. 5. Li Y, Wang X, Blau DM, et al. Global, regional, and national disease burden estimates of acute lower respiratory infections due to respiratory syncytial virus in children younger than 5 years in 2019: a systematic analysis. Lancet 2022; 399(10340): 2047-64. 6. Glenn-Otto S, Dziacky A. Prevention Strategies for RSV Infection in Infants. Pediatrics In Review 2025; 46(4): 228-30. 7. McLaughlin JM, Khan F, Begier E, Swerdlow DL, Jodar L, Falsey AR. Rates of Medically Attended RSV Among US Adults: A Systematic Review and Meta-analysis. Open Forum Infect Dis 2022; 9(7): ofac300. 8. U.S. Centers for Disease Control. Preliminary Estimates of RSV Burden for 2024-2025. [Online] 19 March 2025 [cited 6 May 2025] Available at: https://www.cdc.gov/rsv/php/surveillance/burden-estimates.html. 9. U.S. Food & Drug Administration. FDA Approves New Drug to Prevent RSV in Babies and Toddlers. Press Release 17 July 2023. [Online] [cited 6 May 2025] Available at: https://www.fda.gov/news-events/press-announcements/fda-approves-new-drug-prevent-rsv-babies-and-toddlers. 10. GSK. US FDA approves GSK’s Arexvy, the world’s first respiratory syncytial virus (RSV) vaccine for older adults. [Online] 3 May 2023 [cited 6 May 2025] Available at: https://www.gsk.com/en-gb/media/press-releases/us-fda-approves-gsk-s-arexvy-the-world-s-first-respiratory-syncytial-virus-rsv-vaccine-for-older-adults/. 11. Pfizer. U.S. FDA Approves ABRYSVO™, Pfizer’s Vaccine for the Prevention of Respiratory Syncytial Virus (RSV) in Older Adults. [Online] 31 May 2023 [cited 6 May 2025] Available at: https://www.pfizer.com/news/press-release/press-release-detail/us-fda-approves-abrysvotm-pfizers-vaccine-prevention. 12. Pfizer. U.S. FDA Approves ABRYSVO™, Pfizer’s Vaccine for the Prevention of Respiratory Syncytial Virus (RSV) in Infants Through Active Immunization of Pregnant Individuals 32-36 Weeks of Gestational Age. [Online] 31 August 2023 [cited 6 May 2025] Available at: https://www.pfizer.com/news/press-release/press-release-detail/us-fda-approves-abrysvotm-pfizers-vaccine-prevention-0. 13. PATH. RSV Vaccine and mAb Snapshot. [Online] Last updated: February 2025 [cited 6 May 2025]. Available from: https://www.path.org/resources/rsv-vaccine-and-mab-snapshot/. 14. Mazur NI, Terstappen J, Baral R, et al. Respiratory syncytial virus prevention within reach: the vaccine and monoclonal antibody landscape. Lancet Infect Dis 2023; 23(1): e2-e21. 15. Langedijk AC, Bont LJ. Respiratory syncytial virus infection and novel interventions. Nat Rev Microbiol 2023; 21(11): 734-49. 16. Mezei A, Cohen J, Renwick MJ, Atwell J, Portnoy A. Mathematical modelling of respiratory syncytial virus (RSV) in low- and middle-income countries: A systematic review. Epidemics 2021; 35: 100444.